Utilization of BioDot Omnia Automated Liquid Dispensing/Handling System to Enhance the Efficiency and Accuracy of High Throughput Biological Assays

PROJECT SUMMARY
The proposed S10 project titled, “Utilization of BioDot Omnia Automated Liquid Dispensing/Handling
System to Enhance the Efficiency and Accuracy of High Throughput Biological Assays” is to respond to
PAR-22-081 Basic Instrumentation Grant (BIG) Program. The mission of the Analytical Instrumentation Core
(AIC) at Boston Medical Center (BMC) and Boston University (BU) is to provide state-of-the-art
instrumentation, services, training, and support to investigators to facilitate research and education. Its main
goal is to contribute to the better understanding of the pathogenesis, diagnosis, and treatment of various
human diseases. The AIC achieves this objective by granting access to high-end instruments that are essential
to advancing the research endeavors of biomedical investigators. These instruments would typically be
financially unfeasible for individual scientists to procure, operate, and maintain. Feedback from our
investigators indicates that having instrumentation within the AIC capable of performing high throughput
sample preparation, assay miniaturization, biomarker profiling, and drug screening is among the most pressing
needs. This need is particularly crucial because several groups are engaged in clinical research projects that
require the preparation and processing of large quantities of biological samples. Additionally, having the ability
to miniaturize assays will enable BU investigators to minimize sample volumes while achieving consistent and
reliable results. The Omnia will be indispensable in facilitating biomarker analysis, developing diagnostic
assays, preparing libraries for next-generation sequencing (NGS), and in exploring novel therapeutics. As a
result, the collective need expressed by multiple investigators has prompted us to examine the feasibility of
acquiring an automated BioDot Omnia liquid dispensing/handling system. The AIC provides services to more
than 200 investigators/labs and has over 10 NIH funded projects that would directly benefit from the BioDot
Omnia System. With this system in place, researchers will be able to conduct their projects more efficiently and
with significantly enhanced precision and accuracy. We propose housing the Omnia System at the AIC, which
is situated on the BU Medical Campus, to ensure equal accessibility to investigators throughout the research
community. Leveraging the AIC's extensive experience and outstanding track record in instrument
maintenance and user training will ensure the system remains in excellent working condition, minimizing
potential downtime. Substantial financial support from the institution, coupled with assistance from an advisory
committee regarding biosafety, publications, and annual progress reports, reinforces their commitment to the
successful integration and utilization of this equipment. Investing in this equipment will allow investigators to
undertake studies of paramount importance across a broad spectrum of research areas, including pulmonary
disease, infectious diseases, neurological diseases, vaccine development, diabetes, obesity, renal diseases,
cardiovascular disease, and drug development.

Public health relevance
PROJECT NARRATIVE The Analytical Instrumentation Core (AIC) at BMC and BU plays a vital role in supporting over 200 principal investigators engaged in basic, translational, and clinical biomedical research. Feedback from their users highlights an immediate need for services and instrumentation capable of facilitating the low, medium, and high throughput processing of samples across a wide range of assays and experiments. The acquisition of a BioDot Omnia system would allow the AIC to directly address this pressing requirement, which would empower our investigators to pursue their critical research studies with greater efficiency and effectiveness.